A Research Program on Advancing Biomedical Glycoproteomics

PROJECT SUMMARY / ABSTRACT
The biomedical relevance of disease-related alterations in protein glycosylation has been recognized for
some time. However, significant challenges remain in translating these observations into robust disease
biomarkers, and in establishing a detailed molecular understanding of how altered protein glycosylation affects
a diverse variety of biomolecular interactions and protein structure / function interplays. Because protein
glycosylation is the end result of complex non-template-driven biosynthetic processes, a protein glycoform profile
is exquisitely sensitive to metabolic irregularities, including those that accompany disease. For these reasons,
the detailed molecular characterization of protein glycosylation is of great biomedical interest in the context of
disease biomarker discovery, and for the purpose of relating disease-induced alterations of protein glycosylation
to protein function. Essential to such endeavors are powerful analytical techniques that can determine the
compositions and structures of protein-linked glycans and their sites of protein attachment in complex and
heterogeneous mixtures. This application to the MIRA program requests support of a research program
dedicated to the advancement of biomedical glycoproteomics through the development, application, and
dissemination of mass spectrometry, tandem mass spectrometry, and ion mobility spectrometry based tools for
interrogating the glycoproteome and determining site-specific protein glycoforms. The goals of this program are
consonant with current NIH priorities, including the recent calls for increased investment in early stage
development of new technologies for biomedical research and ongoing initiatives to catalyze advancements in
glycoscience. The new technologies that will result from this work will be generalizable and thus applicable to
the elucidation of site-specific protein glycoform patterns in an eclectic array of biomedically-relevant contexts.

Public health relevance
PROJECT NARRATIVE Most proteins are naturally decorated with sugars, and it is well-known that many diseases are caused by or result in changes to the number or types of sugars that are attached to proteins. This is of great significance to human health because these changes can alter protein structure, function, and activity, and may be useful for detecting disease. This research program is dedicated to the development of novel and innovative analytical tools that can be used to characterize the biomedically relevant profiles the sugars that modify proteins.